Research Training in Rehabilitation for Brain Injury and Neurological Disability

Project Summary
This is an application for the competitive renewal of a T32 Institutional National Research Service
Award for a successful postdoctoral training program in medical rehabilitation research that
focuses on brain injury and neurological disability. We propose to train 4 postdoctoral level trainees
per year, each for a total duration of 2- 3 years. The training program is based in the Johns
Hopkins Department of Physical Medicine and Rehabilitation (PM&R) and in the Kennedy
Krieger Institute in Baltimore. Kennedy Krieger is a major center for clinical care and research on
neurological disabilities in children and young adults on the Johns Hopkins University medical
campus. Trainees have the opportunity to work with faculty advisors from the Kennedy Krieger
Institute, the Department of PM&R, the Johns Hopkins Bloomberg School of Public Health, and
the departments of Neurology, Neuroscience, Otolaryngology, Biomedical Engineering and
Mechanical Engineering. The mission of the program is to train postdoctoral researchers how
to translate advances in neuroscience into neurorehabilitation interventions to improve
outcomes for children and adults with neurologically based disabilities. The goals of the program
are to: 1) train clinicians and basic scientists who will go on to make important contributions that
advance the rehabilitation of patients with brain and spinal cord injuries and other neurological
disabilities; 2) equip these trainees with the skills needed to become independent grant-funded
investigators. The focus of the training program is on a mentored period of hypothesis-driven
translational clinical and/or laboratory based research. Faculty have expertise in one or more of
three major rehabilitation themes: 1) CNS plasticity and recovery; 2) pediatric brain injury
rehabilitation; 3) stroke rehabilitation. A training program management committee provides
specific goals for progress of trainees to achieve core research competencies, and they monitor
progress closely. The program provides a strong curriculum of weekly conferences, journal clubs
and didactic lectures that reflect the research and scholarly environment at Johns Hopkins. The
program has trained more than 50 researchers since its inception, many of which now have
highly productive rehabilitation research programs of their own.
!

Public health relevance
Project Narrative This training program is directly related to improving treatment and reducing disability for millions of children and adults with disorders of the nervous system. Our focus is on training MD and PhD researchers to develop and assess new rehabilitation approaches for people suffering from many different disorders of the nervous system, including traumatic brain injury, stroke, and developmental brain disorders.